CORE--BIOSTATISTICS SHARED RESOURCE

The role of the Biostatistics Shared Resource (BSR) is to provide statistical support to Cancer Center investigators in all program areas: clinical, experimental, and cancer prevention. Given that most cancer researchers have limited training in biostatistics, the support by this Resource addresses a key need within the Cancer Center. The BSR provides support to peer-reviewed funded cancer research, NYU peer-reviewed unfunded clinical trials, new research initiatives, and other cancer studies in decreasing order of priority. Several doctoral level faculty members devote a fraction of their time to the Biostatistics Shared Resource; this arrangement provides a wide range of statistical expertise and the ability to address concurrent needs of various Cancer Center investigations in a timely fashion. The aims of the Resource include collaboration with Cancer Center investigators in the design, methodology and analysis of research projects. This includes support pertaining to, for example, research design, sample size and sample selection procedures, randomization and blinding procedures, measurement issues, and appropriate strategies and methods for statistical analysis. Biostatistics members work with the Cancer Center investigators in the analysis of data and participate in the interpretation and publication of results. In addition, the BSR provides statistical and methodologic review of NYU clinical protocols that have not been peer reviewed. This Resource provides statistical support for a large number of cancer studies (e.g. 80 studies in the last year), which indicates the BSR has developed consultative/collaborative relationships with numerous Cancer Center investigators. The level of activity is expected to growth with the development of new programs and new research directions that require more extensive statistical analyses (e.g., translational research cancer genetics).